TREATMENT OF RHEUMATOID ARTHRITIS BY BACTERIAL DNAJ DESENSITIZATION

Determine if oral administration of DNAj peptides can dimimish hypersensitivity to the antigen and lead to clinical improvement. Test the effects of oral peptide administration on mechanisms of T cell recognition and reactivity to bacterial DNAj and to assess the effect of oral peptide administration on clinical measurements of joint inflammation.